The 3D architecture of the mitochondrial nucleoid and its role in organelle regulation

PROJECT SUMMARY / ABSTRACT
The structure of the mitochondrial genome and its role in mitochondrial function are largely unexplored.
Mistakes in the regulation of mitochondrial DNA can lead to a number of human diseases that can manifest at
any age and in any organ including motor neuropathies, kidney dysfunction, infertility, cardiomyopathy, and
neurodegeneration. Generally, the packaging of DNA and its resulting higher-order structure are critically
involved in the regulation of gene expression, genome replication, and genome segregation in both eukaryotic
and prokaryotic organisms. It is well known that the mitochondrial genome exists as a nucleoprotein complex
called a nucleoid, and a single mitochondrion hosts, on average, 5 copies of the genome, resulting in between
100 and 10,000 copies per cell. There is a significant lack of knowledge on how the genome is structured in
organello, how this structure differs between cell types, and how this structure is misregulated in disease.
Further, it is not known if individual nucleoids within a single mitochondrion have different structures and serve
different functions.
A critical first step to understanding the structure of the mitochondrial genome is to develop and optimize
techniques to characterize the overall three-dimensional architecture of the nucleoid. We propose adapting
several powerful, high-resolution technologies, and combining the knowledge gained from each to develop
models of the organization of the mitochondrial nucleoid. We will optimize Hi-C to map physically interacting
regions of the mitochondrial genome, ATAC-seq and NOMe-seq to determine regions of open and accessible
DNA, and ChIP-nexus to develop high-resolution maps of the major nucleoid binding proteins. We will carry
these studies out in several distinct human cell lines, which have been shown to have different energy
requirements and thus different mitochondrial gene expression. Further, we will adapt this system to
differentiating myoblasts in which mitochondrial biogenesis is highly upregulated. Using these powerful
techniques, we will determine the role of the major transcription factor and structural protein TFAM in
establishing and maintaining genome structure. We will use known disease mutants to understand how the
genome structure is disturbed in disease. Finally, we believe that heterogeneity may exist between nucleoids
within a mitochondrion. To this end, we will develop methods to fractionate different populations of nucleoids
from mitochondria to characterize how their overall architectures differ. In summary, this proposed research will
advance our knowledge of mitochondrial genome structure, allowing us to better understand how mitochondrial
genes are regulated and how genome replication and copy number are regulated. This knowledge will be
invaluable in understanding how mitochondrial mutants lead to disease.

Public health relevance
PROJECT NARRATIVE Mitochondrial dysfunction causes a wide range of disorders that can manifest at any age and any organ with symptoms varying from vision and hearing deficits to cardiomyopathies to neurodegeneration. A critical step in understanding mitochondrial biology, and also mitochondrial disease, is to determine how the genome of the mitochondria is organized and how this structure directs organelle function. This research proposes to develop tools to further our knowledge of mitochondrial genome architecture and to dissect the mechanism of several key mitochondrial DNA proteins, putting us closer to understanding how mitochondrial DNA is regulated and how defects lead to disease.